Remotely Delivered Cardiac Rehabilitation for Adolescents with Congenital Heart Disease

PROJECT SUMMARY/ABSTRACT
Adolescents with congenital heart disease [CHD], including repair of tetralogy of Fallot [TOF], dextro-transposi-
tion of the great vessels [d-TGA], or functionally univentricular heart physiology [Fontan], have lower cardiorespir-
atory fitness [FIT] compared with healthy peers. FIT is a well-established predictor of morbidity, quality of life
[QOL], and heart transplantation and is among the strongest predictors of mortality in this population. However,
adolescents with CHD have significantly lower FIT when compared to cardio-typical peers, due to abnormal
hemodynamics as well as low durations and intensities of physical activity [PA] and exercise. Pediatric cardiac
rehabilitation [CR] programs which prescribe aerobic and resistance exercise over 12-wks. have demonstrated
improvements in FIT for patients with CHD which persist months after completion of the program. Unfortunately,
few hospitals/clinics offer CR programming for children and adolescents due to the financial costs of building
and maintaining a CR facility, as well as the travel cost, time requirement, and burden for parents/caregivers
to transport their child to/from a hospital for CR exercise sessions multiple times per week. In-home CR reduces
barriers related to patient access and the financial burden for hospitals, though data supporting the effectiveness
of in-home CR for youth is limited. The use of group video conferencing technology via tablet computer repre-
sents a novel and potentially transformational strategy for delivering real-time, live, supervised CR to groups of
adolescents with CHD in their homes. The goal of this K23 research plan is to evaluate the effectiveness of video
conferencing for the delivery of real-time CR to groups of adolescents with CHD in their homes. We propose a
12-wk. randomized-controlled clinical trial assigning 74 adolescents [12-19 years old] with 1 of 3 CHD diagnoses
[Fontan, TOF, or d-TGA] to Remote CR [RCR] [in-home, live, remote group exercise, 3-45-min sessions/week.]
or Active control [in-home, self-directed exercise]. Our aims will assess the effectiveness of the RCR approach
by comparing between-group changes [0-12 weeks] in: FIT, cardiac function, lean body mass, and frailty. Ex-
ploratory aims will assess between group differences [0-12 weeks] in physical function, QOL, PA self-efficacy,
and will evaluate the impact of demographic characteristics on program participation and satisfaction, and daily
PA. We hypothesize the RCR intervention will elicit greater improvements in each outcome compared to the
control group. The PI’s short term career development goal of enhancing knowledge, skills, and experiences in
clinical trials research, CHD physiology, and implementation and dissemination [I&D] outcomes research in youth
with CHD will be accomplished through a multidisciplinary team of mentors, formal programming/coursework,
independent study, and scientific meetings. Career development training and experiences and data from the
research plan will prepare the PI to accomplish his long-term career goals to 1] establish an independently
funded research program conducting clinical trials to evaluate the impact of exercise, FIT on physical and psy-
chosocial function in youth with CHD; and 2] I&D of CR programs across multiple sites.

Public health relevance
PROJECT NARRATIVE Cardiorespiratory fitness [VO2peak] is one of the strongest predictors of cardiac related co-morbidities including physical and psychosocial function, quality of life, heart transplantation, and mortality in those with congenital heart disease [CHD]. The primary aim of the proposed clinical trial is to evaluate the effectiveness of a remotely delivered, in-home, supervised cardiac rehabilitation [CR] exercise program delivered to groups of adolescents with congenital heart disease [n=74] by live health coach via group video conferencing technology; thus eliminating barriers related to accessibility for patients/families who may not have the capability or resources to travel to a regional children’s hospital multiple days per week for traditional in-hospital CR. If our remotely delivered, group based approach for pediatric CR is found to be effective for increasing cardiorespiratory fitness, cardiac function, and other markers of physical and psychosocial health, the implementation of this approach across multiple centers has the potential to improve a patient’s health, wellbeing, and resistance to physiologic stressors, reduce severity of illness and co-morbidities, and potentially lengthen life for children and adolescents with congenital heart disease.